THE AAAS BLACK CHURCH HEALTH CONNECTION PROJECT

Because of the need to increase the number of Blacks who are scientifically literate and who understand health issues related to drug abuse, AAAS proposes to develop and field test a set of hands-on and participatory biology activities. These activities will be disseminated to over 500 churches who are a part of the AAAS Black Church Network, as well as to other churches that are interested in conducting informal biology activities. Activities will be suitable for use in after-school programs, health fairs, community health days in housing projects, health Sunday at churches, and exhibits in shopping malls and grocery stores. Other features of this project include: a competition for health professionals who are interested in developing activities for use in this project. development of a volunteer program for health professionals who want to work in churches. Products of this project will include a manual with activities and guidelines on how to use these activities in a variety of community settings. Field testing will be done in Pittsburgh, PA.; Lafayette, LA; Birmingham, AL; Washington, DC; and Baltimore, MD. Partners in this effort include science museums, urban leagues, schools, colleges, universities and professional associations.